Decoding Mosaic Chromosomal Alterations in Lymphoid Malignancy Risk and Outcomes

ABSTRACT
Lymphoid malignancies are common forms of cancer and leading causes of death that currently have no
approach for prevention nor interception. Early data support clonal hematopoiesis in the form of mosaic
chromosomal alterations (mCAs) as a promising premalignant and prognostic biomarker. mCAs are
somatic megabase-scale alterations that can be detected with high sensitivity from array-based genotyping of
blood-derived DNA. Prior studies have found mCAs confer a 10-fold increased risk of developing a lymphoid
malignancy and 2-fold increased risk of mortality. However, prior studies have not been powered to
precisely investigate mCAs in major lymphoid subtypes. Deeper characterization by subtype is needed.
The overall objective of this application is to determine the role of mCAs in risk and prognosis of lymphoid
malignancies. Our central hypothesis is that mCA carriers have distinctive etiologies and inferior outcomes.
The rationale for this project is that mCA events can be readily detected in peripheral blood and could allow for
targeted screening and earlier detection of at-risk individuals, promoting future prevention. We will utilize our
existing studies, the most diverse prospective cohorts of lymphoma survivors in the world, to evaluate mCAs
across lymphoid malignancies. Aim 1 will evaluate the association between mCAs and risk of lymphoid
malignancy subtypes. Our hypothesis is that certain mCA loci are associated with risk of specific lymphoid
subtypes. We will first evaluate the effect of mCAs across subtypes in 34,519 prevalent cases compared to
63,103 controls. Then we will validate these results in 5,029 incident cases and >500,000 controls. Aim 2 will
determine the prognostic role of mCAs in lymphoid malignancies. Our hypothesis is that patients with an
mCA have worse outcomes than those without an mCA. We will examine outcomes in 10,353 patients from the
MER and LEO cohorts, accounting for therapy, known prognostic factors, mCA loci, and ancestry. Aim 3 will
elucidate the blood cell lineage of mCAs in patients with a lymphoid malignancy. We will compare mCA
events from peripheral blood with chromosomal alterations in matched tumor tissue in 2,164 patients. Then we
will generate data to explore if mCAs are restricted to lymphoid cells in lymphoid malignancy patients.
Completing these aims will provide a deeper understanding of the relationship between mCAs and lymphoid
malignancy subtypes. Together, these studies will pave the way for future modeling of lymphoid malignancy
risk and prognosis. We anticipate that the results of this project will generate critical preliminary data for future
research on mCAs, specifically regarding (a) mechanisms underlying the risk of lymphoid malignancies, (b)
therapeutic and prognostic implications, and (c) broader outcomes, such as susceptibility to infections and
cardiovascular disease. The resulting preliminary data and additional mentored training from this award will
propel me towards my long-term goal of establishing an independent research program to improve prevention,
interception, and outcomes of blood cancers.

Public health relevance
NARRATIVE Lymphoid malignancies are common cancers and leading causes of cancer death that currently have no approach for prevention nor interception. A promising biomarker associated with risk of lymphoid malignancies is clonal hematopoiesis in the form of mosaic chromosomal alterations (mCAs). The goal of this application is to determine the role of mCAs in risk and prognosis of the most common lymphoid malignancy subtypes.